Prescription Drug Monitoring Program Integration in the Electronic Health Record

PROJECT SUMMARY
Prescription Drug Monitoring Programs (PDMPs) are state administered electronic registries of
controlled-substance prescription dispensing data and are used by clinicians to inform prescribing decisions for
medications of abuse. Now operating in every state and the District of Columbia, PDMPs are a central strategy
in the nation’s response to the opioid overdose epidemic. A growing literature suggests that state PDMPs
reduce high-risk opioid prescribing and opioid-related overdoses, particularly in states that mandate use in
certain clinical situation. However, PDMP use varies among clinicians because access often entails
interrupting the clinical workflow or patient care encounter. To promote increased PDMP use, multiple states
are investing in technology that facilitates PDMP integration in other health information technology (HIT)
platforms such as the electronic health record (EHR). In an effort to accelerate integration, the Oregon Health
Authority is subsidizing PDMP EHR integration for healthcare systems across Oregon. Oregon Health &
Science University (OHSU), one the largest healthcare systems in the state, will be one of the first healthcare
systems to undergo PDMP integration within its EHR application (Epic™). OHSU is currently integrating PDMP
access across twelve ambulatory primary care medicine clinics over a six-month period (four clinics starting
every two months). The objective of this proposal is to evaluate the effect of PDMP integration on provider use
and prescribing behavior. We accomplish this objective with two Specific Aims: (1) Determine the effect of
PDMP EHR integration on provider PDMP use and, (2) Evaluate the effects of PDMP EHR integration on
controlled substance prescribing. We will use an observational stepped-wedge design with data derived from
OHSU EHR and the state’s PDMP program. We exploit the staggered implementation across OHSU clinics to
estimate the effects of PDMP EHR integration on provider use of the PDMP (Aim 1) and prescribing behavior
(Aim 2). Data generated from this project will inform PDMP integration efforts across the country and support a
larger research proposal to study the effects that initiative on opioid prescribing and opioid-related overdose
outcomes.

Public health relevance
NARRATIVE Prescription drug monitoring programs (PDMPs) play a central role in the nation’s response to the opioid crisis and emerging evidence suggests they have a positive effect on prescribing and opioid-related overdose deaths. Because one of the most commonly cited barriers to regular PDMP use include time and workflow interruptions, many states are developing technological enhancements to facilitate PDMP integration within health informatic technology platforms such as the electronic health record (EHR). The objective of this study is to evaluate the effect of PDMP integration in the EHR on PDMP use and prescribing behavior within primacy care clinics in a large academic medical center and affiliated community clinics in Oregon.